Role of Tim-l in B Cells in regulating autoimmunity in the CNS

PROJECT SUMMARY
Accumulating evidence supports that B cell can regulate immune responses and are essential for limiting
inflammation and autoimmunity by IL-10-dependent and -independent mechanisms. The processes and
mechanisms by which B cells with regulatory properties are generated have also not been identified. We have
shown that Tim-1 is also expressed on B cells that produce IL-10 and Tim-1 is required for apoptotic cell (AC)
binding to B cells and induction of IL-10. We generated a mouse with a conditional deletion of Tim-1 selectively
on B cells (Tim-1BKO). The Tim-1BKO mice show progressive loss of IL-10 production in B cells and, with age,
developed severe multi-organ tissue inflammation including colitis, dermatitis, hepatitis and a paralytic disease
with meningeal inflammation in the CNS. On the other hand, Tim-1BKO mice show strong anti-tumor immunity
with inhibition of tumor growth. Therefore, in addition to serving as a marker for regulatory function of B cells,
Tim-1 as a phosphatidylserine receptor is also functionally required for optimal regulatory B cell function.
However, it is not clear what induces Tim-1 expression and what are the transcription factors that drive Tim-1
expression and regulatory B cell function. Our data clearly shows that Tim-1 does not define a subset of B cells
but can be induced on B cell upon activation. Based on the preliminary data we hypothesize that Tim-1 is a
functional marker on B cells that can induce IL-10 upon binding to AC and regulate tissue inflammation,
autoimmunity, and anti-tumor immunity. To address this hypothesis we propose to: 1) Identify Transcriptional
Regulators of Tim-1+ B cells, focusing on EHF as the positive regulator of Tim-1, which was identified by a
focused Crispr-Cas9 screen; 2) Study the effect of loss of Tim-1 on B cells in generating pro-inflammatory
effector B cells, as Tim-1BKO B cells are highly activated and produce proinflammatory cytokines including IL-23
and IL-6 which promote differentiation of pathogenic Th17 cells; 3) Study the role of Tim-1+ B cells in maintaining
stem-like Th17 cells and limit differentiation of pathogenic CXCR6+ Th17 cells. We have found that Tim-1+ B
cells produce Wnt10a, which promotes stemness, and other suppressive cytokines that keep Th17 cells in a
stem-like state and limit their differentiation into pathogenic Th17 cells. The proposed studies will greatly increase
our understanding of the role of Tim-1 in B cells and the generation of regulatory activity on B cells to promote
immune tolerance and limit tissue inflammation and autoimmunity. These studies will provide a novel therapeutic
strategy by targeting B cells for the treatment of autoimmune diseases and promoting anti-tumor immunity.

Public health relevance
PROJECT NARRATIVE B cells can profoundly influence the immune response by expressing cytokines and co-receptors that either promote (effector B cells) or regulate (regulatory B cells) autoimmunity and anti-tumor immunity. We discovered that TIM-1 identifies B cells that possess regulatory properties by binding to phosphatidylserine expressed on apoptotic bodies. In this R01 we will determine the molecular mechanisms and transcription factors that induce Tim-1 expressing B cells with an aim to identify targets by which the regulatory properties of B cell can be manipulated to regulate autoimmunity and anti-tumor immunity.